Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
This Core facility is the administrative structure of the Yale Liver Center, and so it is designed to ensure that the
Center functions are integrated and cohesive. The Core also ensures that the Center can meet both current and
evolving needs of its members and potential members. It simultaneously tries to match the needs to advance in
the field of hepatology and related areas in the basic science disciplines that form the basis for these advances.
The Administrative Core interacts with the other components of the Center through the following specific aims:
A. To maintain centralized offices for the administration of this DDRCC; B. To provide administrative assistance
for the coordination of personnel involved in each Core of this Center; C. To maintain fiscal records and
accountability for each component of the Center; D. To coordinate the development of all annual reports and
renewal applications for the Center; E. To plan and schedule meetings of the Executive Committee and to
maintain its minutes; F. To facilitate the Director’s activities as scientific overseer of the Center, particularly with
respect to the administration of the Research Core facilities and Pilot Feasibility Projects; G. To plan, organize,
and publicize Center seminars, special symposia, and bi-annual retreats; H. To solicit and oversee the review
and award of Pilot feasibility grant applications; I. To prepare for and organize annual meetings of the Center’s
External Advisory Board; J. To maintain two-way communication with the membership, including development
and distribution of a quarterly newsletter, conducting periodic surveys to assess evolving needs, and outreach
to publicize new resources; K. To maintain and update the Liver Center’s Web page accessed through Yale
University’s web page (livercenter.yale.edu); and L. To maintain a record of the usage of each component of
each core, plus publications arising from participation in the Center. This Core facility is supervised by the Center
Director, Dr. Nathanson, and the Deputy Director, Dr. Strazzabosco. Ms. Abu-Hanna is responsible for Project
Management and Mr. Wanciak is responsible for the day-to-day accounting for the Center.